Identification of small molecule RXFP3 ligands

The NCATS Early Translation Branch (ETB) hosts a broad and comprehensive program for the discovery of drug candidates directed towards rare diseases and pharmacological tools to probe the function of the human genome. ETB conducts research to understand the underlying principles driving the translation of basic research discoveries into tangible improvements in human health.

Novel small molecule RXFP3 agonists and antagonists will be valuable tools to elucidate relaxin-3's function, as well as its actions at RXFP3 receptors. During this period, the project team has worked to develop and characterize screening hits to identify a potent RXFP3 modulator.